Thyroid Physiology Studies of Inherited Disorders

PROJECT SUMMARY
The broad objective of this research proposal is to advance our understanding of thyroid physiology through the
study of genetic defects at key regulatory processes. In addition to identification of new syndromes and gene
defects, research centers on regulation of gene expression and gene therapy. The program owes its success to
the worldwide referral of patient material, to the clinical and technical skills of the PI’s laboratory, and to
collaborative arrangements with accomplished investigators from the US and abroad that provide
complementary knowledge and technical expertise. The proposal by multiple PIs for continuing funding
encompasses three aims. (1) Determine the mechanism by which several newly identified genetic defects
produce the observed thyroid phenotypes. These include the selenoenzyme deiodinases D1 and D3; PKHD1L1
mutations by studying the Pkdh1l1KO mice; and LRP2 mutations by in vitro structural and functional
characterization. (2) Determine the mechanism of resistance to TSH (RTSH) caused by mutations in a primate-
specific short tandem repeat (STR) on chromosome-15. Human thyroid organoids recently developed in
collaboration will be used to generate STR mutant thyroid organoids using CRISPR/Cas9 or PiggyBac
transposon as a genome editing tool, in order to study the physiological function of this primate specific STR and
its role in the dominantly inherited phenotype of RTSH. TSH sensitivity of normal and mutant organoids will be
determined in vitro or in vivo after transplantation into hypothyroid mice. (3) Determine the effectiveness of
combined gene and thyroid hormone (TH) analogue treatments in monocarboxylate 8 (MCT8) deficiency. The X
chromosome linked MCT8 deficiency produces in boys a disease known as Allan-Herndon-Dudley-Syndrome
(AHDS) with severe neuropsychomotor defects, caused by deficiency of TH transport in brain, and systemic
thyrotoxicosis caused by excess of circulating T3. Double knockout (dKO) mice, lacking Mct8 and the TH
transporter Oatp1c1, recapitulate the findings of AHDS. We recently showed that gene therapy in peripubertal
dKO mice with adeno associated virus 9 (AAV9) containing the human MCT8 cDNA improved the locomotor and
cognitive function by near normalization of brain T3 content but failed to correct the serum thyroid tests. We
propose to add the TH analogues diiodothyropropionic acid (DITPA) or triiodothyroacetic acid (TRIAC) that are
known to correct the thyrotoxicosis of AHDS in peripheral tissues but not the neuropsychomotor manifestations,
to achieve rescue of this incapacitating disease. The proposed research will result in the discovery of new genes
and mechanisms causing congenital and inherited thyroid diseases. In addition to knowledge gained regarding
thyroid physiology and pathophysiology, these studies will provide the means for rapid and specific diagnosis
and for rationale of innovative treatments.

Public health relevance
PROJECT NARRATIVE The broad objective of this research proposal is to advance our understanding of thyroid physiology through study of genetic defects at key regulatory processes. The project involves three aims: (1) expand the study of newly identified genetic defects that affect thyroid physiology; (2) characterize the mechanism of resistance to thyrotropin caused by mutations in a primate specific non-coding DNA sequence; (3) determine the effectiveness of combined gene therapy and thyroid hormone analogue administration as a preclinical treatment for monocarboxylate transporter 8 deficiency. Elucidating the mechanisms of these conditions will result in unprecedented knowledge of thyroid physiology and provide scientific rationale for targeted treatments.